Optimizing theranostic radiopharmaceutical therapy to combat resistance to PARP inhibition in advanced ovarian cancer

Project Summary (limited to 30 lines)
Ovarian cancer is a devastating gynecologic malignancy with 13,770 estimated US deaths in 2021 with a 49.1%
relative 5 year survival rate (SEER). Leveraging the considerable fraction of women with ovarian cancer who
have germline or somatic homologous recombination deficiencies (HRD), poly (ADP-ribose) polymerase 1
inhibitors (PARPi) have become standard of care for ovarian cancer. Unfortunately, most patients treated with
PARPi develop resistance. Interestingly, most PARPi resistant patients continue to express activated PARP-1
(the target of PARPi) in the nucleus. This finding has guided our alpha theranostic radiopharmaceutical approach
to treating PARPi-resistant ovarian cancer to deliver cytotoxic alpha particles directly to the nucleus of cancer
cells to create lethal, double stranded DNA breaks. Our platform is based on a small molecule similar to the
approved PARPi, rucapararib, labeled with 18F for PET ([18F]fluorthanatrace, [18F]FTT) and 211At for alpha
therapy ([211At]parthanatrace, [211At]PTT).
Our overarching hypothesis is that [211At]PTT can overcome PARPi resistance with an acceptable therapeutic
ratio and that the theranostic pair of [211At]PTT and [18F]FTT will allow accurate pre-treatment dosimetry to
guide both efficacy and tolerability of therapy. Using mouse models of ovarian cancer, we plan to (1) measure the
comparative dynamic biodistribution of the proposed theranostic pair, [18F]FTT and [211At]PTT to verify
preliminary data supporting similar tumor uptake and tissue kinetics, (2) understand the dose-response
relationship in tumor and organs at risk (both those expressing considerable PARP-1 and those with off target
agent biodistribution); (3) carry out pre-clinical studies to assess toxicity and efficacy of the [211At]PTT /[18F]FTT
theranostic approach with optimized dose fractionation. Our specific aims are as follows:
SA1—Biodistribution and Pharmacokinetics: Test the comparative biodistribution of [18F]FTT and
[211At]PTT in normal tissue and ovarian cancer.
SA2—Dose-response relationship: Develop and validate on- and off-target normal organ dose
limits and tumor dose-response relationship utilizing [18F]FTT PET/CT to predict dosimetry
from [211At]PTT.
SA3—Pre-clinical trials: Determine the optimal dosing scheme and estimate efficacy in patient
derived ovarian cancer murine models.
Successful completion of these aims will provide data needed for a first in human clinical trial of [18F]FTT -guided
[211At]PTT therapy in women with advanced PARPi-resistant ovarian cancer and will provide insight into tumor
factors mediating effective alpha particle therapy to guide patient selection in clinical trials and clinical practice.

Public health relevance
Project Narrative (3 sentences) In this project, we aim to better understand the comparative radiobiology of the alpha emitting drug [211At]PTT in tumor and normal tissues. We will develop an optimized strategy for translation to clinical trials in women with advanced PARPi resistant ovarian cancer. The PET imaging companion diagnostic [18F]FTT will be developed in parallel as a prognostic biomarker as well as for image-guided treatment planning.